Mechanism of Meiotic Recombination

Our research examines the molecular mechanism of recombination and DNA damage repair in the yeast Saccharomyces cerevisiae. Our primary focus is on meiotic recombination, but we also study events that occur during vegetative growth. Current research involves three aspects of these complex biological processes: Initiation of meiotic recombination: Meiotic recombination is initiated by DNA double-strand breaks (DSBs); both the location and timing of break formation is tightly controlled. Our aim is to determine the proteins that form DSBs, their substrate requirements, and the factors that control their location, frequency and timing. Current research is directed at determining the composition of the protein complex that catalyzes DSB formation and at determining the chromosome structural elements that determine where DSBs do and do not form. Mechanism of meiotic recombination: We have developed techniques to isolate and characterize unstable intermediates in meiotic recombination, and have used these techniques to demonstrate that the two classes of meiotic recombination (events associated with crossing-over versus events not accompanied by crossing-over) procede by distinct molecular mechanisms. Our current aim is to determine the repair proteins that participate in both pathways, that are uniques to one or the other pathway, and that determine the choice between crossover and noncrossover recombination. Chromatin modification and double-strand break repair: We are examining changes in chromatin structure and modification that occur in response to DNA double-strand breaks, using as a model system a single DSB formed by the HO endonuclease in vegetative cells. We have shown that a large region of chromatin (> 40 kb) is modified, by phosphorylation of histone H2A, in response to this defined DSB. We have also obtained evidence for chromatin remodeling by nucleosome removal within ~2kb of a DSB. Current research is aimed at determining the proteins responsible for this DSB-associated chromatin modification and remodeling, and at examining similar events in meiosis.